Delphi and associated resources: maintenance and further development; Administrative Supplements to Support Undergraduate Summer Research Experiences

With this administrative supplement we are seeking support for summer salary for a undergraduate student,
Mr. Nicolas Ancona, who is currently working with us as a volunteer. The original R01GM093937 grant does
not have funds designated for undergraduate student’s research and we are using this administrative
supplement option to support Mr. Ancona for summer research in 2023. He will be working on a project which
within is along the aims of the original R01GM093937 proposal, namely to further benchmark SAMPDI-3D
software and to test its performance of various set of cases, specifically on single nucleotide variants. I will be
closely monitor his work and provide the training. Such a research will contribute to Mr. Ancona professional
growth, will enable him to develop skills to carry out scientific investigations and to work with other
researchers. From scientific point of view, the investigation will demonstrate the distribution of the binding free
energy changes caused by mutations in case of protein-DNA complexes, emphasizing on the differences
between researcher-initiated mutations versus mutations that can be observed in human population.

Public health relevance
Project narrative Electrostatic interactions and the corresponding electrostatic energy components are essential for the function, stability, and interactions of virtually all biological macromolecules, nanoparticles, and substrates. Thus, further development and maintenance of the DelPhi package and associated resources will be beneficial for the biomedical community in its efforts to reveal the molecular effects of human genetic disorders. Revealing molecular effect of disease-causing mutations facilitates early assessment of disease risk and development of therapeutic solutions.